Regulation of blood-retina barrier by placental growth factor

Project Abstract
Diabetic retinopathy (DR) is a common complication of diabetes causing vision loss. Diabetes-
induced metabolic abnormality and mitochondrial dysfunction resulting in oxidative stress is a primary
pathogenic factor driving DR onset and development. This proposal will complete the two Aims: (1) To
elucidate how placental growth factor (PlGF) mediates DR-related pathology by suppressing glucose 6
phosphate dehydrogenase (G6PD) activity and oxidative pentose phosphate pathway (oxPPP) flux. (2) To
determine the protective role of G6PD’s antioxidant function via oxPPP in retinal cells against diabetes-
induced oxidative injury. More specifically, the PlGF signaling pathway molecules involved in regulating
G6PD expression and activity will be uncovered. The new mechanisms by which PlGF mediates diabetes-
induced retinal endothelial cell barrier dysfunction and other DR-related pathologies through the metabolic
shift from PPP to glycolysis and mitochondrial dysfunction will be elucidated in cell cultures and murine
models. G6PD’s protective role in DR will be determined using cell-/tissue-specific G6PD conditional
knockout (cKO) and conditional overexpression (cOE) mice, as well as AAV-based G6PD expression
vector and small-molecule G6PD activator. Overall, the research is designed to elucidate the regulation
and role of the “diabetes-PlGF-G6PD-oxidative stress” signaling cascades in DR pathogenesis. The
outcomes will give mechanistic insight into DR pathogenesis in general and PlGF function in particular.
Since that PlGF has emerged as a promising target molecule to treat DR and diabetic macular edema
(DEM), understanding the underlying mechanism is significant. Given the central role of G6PD-gated
oxPPP in regulating redox homeostasis and cell survival under stress conditions, this project will fill a
critical knowledge gap regarding whether G6PD’s antioxidant function via oxPPP plays a pivotal role in
protecting retinal cells from diabetes-induced oxidative damage and compromised G6PD activity and
limited oxPPP flux contribute to DR pathogenesis. To examine metabolic flux and mitochondrial function,
quantitative measurements will be applied, including stable labeling tracer [1,2-13C2]glucose, liquid
chromatography/mass spectrometry, targeted metabolomics, oxygen consumption rate/extracellular
acidification rate. Cutting-edge approaches will be employed to determine G6PD’s protective effect, such
as gene silence (shRNA), genetic models (cKO and cOE mouse), CRISPR-Cas9 genome editing, virus-
based gene transfer, and pharmaceutical compounds. In summary, this project is innovative because it
will elucidate a novel mechanism for PlGF to mediate DR-related pathology by regulating glucose
metabolism and provide new insights into the question(s) “why or how are retinal cells become vulnerable
to diabetes-induced oxidative stress?”. It will also explore the new approaches to prevent or delay DR and
DME development by enhancing antioxidant capacity.

Public health relevance
Project Narrative Diabetic retinopathy (DR) is a common and sight-threatening complication of diabetes. Placental growth factor (PlGF) has emerged as a promising target molecule to treat DR, yet how PlGF mediates DR pathogenesis remains incompletely understood. This project will elucidate a new mechanism for PlGF to mediate diabetes-induced retinal pathology by reprogramming glucose metabolism, determine the protective role of glucose-6-phosphate dehydrogenase (G6PD)’s antioxidant function via oxidative pentose phosphate pathway (oxPPP) in DR, and explore a new intervention approach to prevent or delay DR progression by increasing G6PD activity and oxPPP flux.